A Feasibility Study of Home-based Exercise for Older Veterans with Serious Mental Illness

Serious mental illness (SMI; schizophrenia-spectrum and bipolar disorders) affects Veterans at high rates and is associated with major difficulties in psychosocial and physical function. The burden of SMI worsens over the lifespan, which makes older Veterans with SMI particularly at risk for functional decline. Existing behavioral treatments are effective at improving psychosocial function but do not increase physical function in older Veterans with SMI. The lack of targeted interventions for physical function in older Veterans with SMI is troubling given that compromised physical function is related to more falls, hospitalizations, nursing home admissions, as well as early mortality. Older Veterans with SMI have significantly lower physical function across mobility, endurance, and strength domains compared to both age- and sex-based population norms and to older Veterans without SMI, further highlighting the magnitude of functional decline. Exercise is an established intervention for increasing all domains of physical function (i.e., mobility, endurance, strength) in older Veterans. Despite a growing research base on exercise for adults with SMI, exercise trials for adults with SMI have been limited by largely focusing on endurance, excluding older persons, and having high dropout rates. Environmental difficulties (e.g., lack of transportation), low motivation, and medical issues affecting older Veterans with SMI contribute to low engagement rates and high dropout rates in facility-based exercise programs. Individualized home-based exercise programs, which are safe and effective for older Veterans with health challenges, could address the main barriers to exercise in older Veterans with SMI by promoting greater accessibility and individual tailoring. To this end, this Career Development Award (CDA-2) will take a systematic approach to develop, refine, and feasibility test a home-based exercise program aimed at improving function in older Veterans with SMI. The home-based exercise program will be modeled after VHA’s Home- based Cardiac Rehabilitation Program, a 12-week program comprised of individualized home-based exercise prescription and weekly telephone health coaching. Further, motivational strategies for exercise (e.g., goal- setting, tracking progress, problem-solving) will be integrated into Home-based Cardiac Rehabilitation telephone health coaching calls. Guided by the successive cohort design, an initial exercise program manual will be developed based on Home-based Cardiac Rehabilitation (with motivational strategies) and qualitative input from key stakeholders (older Veterans with SMI, clinical staff and leadership serving older Veterans with SMI). The initial manual will be tested in a small 12-week open trial of two successive cohorts of older Veterans with SMI (n=5 in each). Qualitative and quantitative feedback on the program and research procedures will be collected and analyzed after each cohort and used to refine the program manual. A 12-week open trial of 30 older Veterans with SMI will then be conducted to evaluate the feasibility and acceptability of the exercise program. Primary outcomes are feasibility and acceptability with secondary outcomes including physical and psychosocial function, depression, motivation, exercise, and quality of life. During the CDA-2 award period, Dr. Browne will engage in didactic, participatory, and career development activities as well as receive expert mentorship in (1) qualitative methods and analysis, (2) intervention development, (3) home-based exercise prescription, (4) health coaching, and (5) clinical trial design. The training and research from this CDA-2 will lead to a VA Merit Award submission and support Dr. Browne’s career advancement. This CDA-2 is a critical step in Dr. Browne’s pursuit of an independent clinical research career committed to developing, evaluating, and disseminating health-promoting interventions to improve function in older Veterans with SMI.

Public health relevance
Older Veterans with serious mental illness (SMI; schizophrenia-spectrum and bipolar disorders) have reduced physical function (i.e., strength, mobility, endurance) that leads to more falls, hospitalizations, and nursing home admissions. Exercise improves physical function in older Veterans; however, environmental difficulties (e.g., lack of transportation), low motivation from mental health symptoms, and comorbid medical issues make participation in facility-based exercise programs challenging for older Veterans with SMI. This CDA-2 will develop, refine, and feasibility test a home-based exercise program for older Veterans with SMI that targets the established barriers impacting exercise engagement in this population. This study will result in the first exercise program designed specifically to improve strength, mobility, and endurance in older Veterans with SMI. This work has the potential to improve the physical and mental health, quality of life, and independence of a population at tremendous risk for functional decline.